The Role of Recycling Immune Complexes in the Breakdown of Tolerance

DESCRIPTION (provided by applicant): The defective clearance of apoptotic cells and the increase in circulating immune complexes (ICs) have repeatedly been implicated in heightened cytokine secretion in systemic lupus erythematosus (SLE). Despite evidence of clearance defects, and presumably diminished access of TLR ligands to the endosome, cytokine secretion has been found to result from activated endosomal TLRs. This paradox raised the possibility that a more complicated model involving TLR-dependent and TLR-independent mechanisms regulates cytokine secretion. Our preliminary data show that IgG-ICs (IgG-apop ICs) bound in part via FcγRs are elevated 30-fold on the surface of DCs and MFs from autoimmune prone MRL/lpr mice. We show that this accumulation results from a degradation defect that promotes the recycling of internalized FcγRs bound IgG-ICs. In vivo and in vitro, the accumulation of ICs heightens BAFF secretion. In this application we will test the central hypothesis that IgG-apop ICs accumulate on DCs and MFs due to defects in targeting or degrading ICs within the endocytic/phagocytic pathway. This leads to pathogenic cytokine production as a consequence of genetic predisposition and chronic TLR and/or FcγRs signaling. We propose in aim 1 to identify where in the degradative pathway the progression of ICs is attenuated. In aim 2, we postulate that chronic FcγRs signaling results when ICs bound to FcγRs remain aggregated during the recycling process, and that chronic TLR signaling results when the IC-loaded FcγRs spend prolonged time within these pathways. Lastly, we propose that although genetic predisposition might underlie the defects leading to the recycling of ICs, genetic events might also be required for heightened cytokine secretion. We will separate these putative genetic events by pharmacologically inducing IC recycling in non-autoimmune mice and assessing whether this leads to heightened cytokine production. Overall, this proposal is significant because it identifies that ICs accumulate on DCs and MFs and defines a more intricate mechanism for how TLR-dependent and TLR- independent mechanisms might contribute to elevated levels of lupus-related cytokines.

Public health relevance
These exploratory studies are relevant to tolerance for two reasons. First, they may provide a mechanism that links the recycling of immune complexes bound by Fcgamma receptors the heightened cytokine production seen in autoimmune disease. Secondly, they will begin to define a previously unappreciated defect that attenuates the degradation of immune complexes allowing their accumulation on the cell surface and activation of the immune system.